Administrative Core

The Administrative Core (AC) will provide the scientific vision and governance structure necessary to develop
and implement the Johns Hopkins Artificial Intelligence and Technology Collaboratory (AITC). The aims are to
provide the interdisciplinary leadership and governance structure to the AITC, to administer and organize the
processes of the AITC, to facilitate the identification of new AI/Tech relevant for use in the developing new
products that will improve the health and wellbeing of older adults, to maintain documents, reports and records,
and to organize and conduct scientific sessions related to science and technology emanating from this AITC.
The AC will be led by the AITC Co-Principal Investigators, who have the relevant interdisciplinary scientific and
clinical expertise, leadership and business development experience, as well as the broad institutional
knowledge necessary to facilitate the goals of this AITC. They will work closely with a program manager and
administrative staff, other Core Directors, and an expert Advisory Committee to develop and promote the
research and product development agenda of this AITC. An experienced External Advisory Panel will also be
named and provide direct programmatic feedback to the AC leadership team. This core will facilitate the
organization of national calls for pilot proposals on an annual basis. It will also seek regular input from
institutional and national leaders who represent aging-focused clinical medicine and research, Alzheimer's
disease research and clinical practice, business and venture capital leaders, and stakeholders and their family
members. The AC will also work to ensure that underserved rural and urban populations are included in all
aspects of this AITC. This core will also work closely with the AITC coordinating center to maintain a living
textbook of content coming from this and other AITCs. In summary, the AC will provide the vision, leadership
and management functions of the AITC through the development and maintenance of a focused and
interdisciplinary program of AI and technology development focused on improving the health and well-being of
older adults. It will assure that this AITC contributes significantly to the development of aging and AD-relevant
AI and technology advances, and will help to assure that these developments are moved into products that
improve the health and well-being of older adults.